Molecular Mechanisms of Somatostatin Interneuron Diversity

PROJECT SUMMARY
The multitude and complexity of cortical functions is shaped by the diversity of cortical interneurons populations.
Specifically, somatostatin interneuron, which comprise one-third of all cortical interneurons, route the flow of
information within the cortex by targeting and selectively inhibiting the dendrites of excitatory pyramidal neurons.
Recent efforts have demonstrated that cortical somatostatin interneurons are themselves further divided into
various subtypes. Many studies have characterized the distinct and heterogenous properties of somatostatin
interneuron subtypes in the functioning adult brain and their diverse contributions to cortical function, but the
mechanisms by which this diversity is generated during development are relatively unknown. Recent studies
have devoted considerable effort into obtaining a descriptive account of interneuron diversification during
development by profiling the transcriptomic and epigenetic events that unfold during cortical interneuron
development, but these studies also fall short of presenting a mechanistic explanation.
Our lab and others have previously demonstrated the requirement of the transcription factor Satb1 for the proper
development of cortical somatostatin interneurons. Interestingly, removal of Satb1 has heterogeneous effects
within the somatostatin interneuron population, suggesting that it may contribute to the generation of diverse
features within the somatostatin interneuron population. Moreover, single-cell transcriptomic sequencing data
shows that Satb1 is expressed at varying levels across distinct somatostatin interneuron subtypes. Thus, In this
proposal, I present the hypothesis that Satb1, in a concentration-dependent manner, contributes to somatostatin
interneuron diversity during development by controlling distinct genetic programs. I will test this hypothesis using
a combination of intersectional mouse genetics, epigenetic and transcriptomic profiling, and microscopy. In Aim
1 I seek to characterize varying Satb1 protein levels across somatostatin interneuron subtypes and the
phenotype of Satb1 removal. In Aim 2 I seek to understand the mechanism by which varying Satb1 levels may
lead to distinct genetic programs. Successful completion of this study will help to elucidate fundamental
mechanisms by which the brain creates neuronal diversity during development. Furthermore, these studies will
highlight new exciting principles for gene regulation. These data along with the research and scientific expertise
developed through this Kirschstein-NRSA F30 Fellowship Award will support my long-term goal of becoming an
independent investigator.

Public health relevance
PROJECT NARRATIVE The past decade in neuroscience has focused on unveiling and characterizing the diversity of neuronal populations, but the developmental mechanisms by which this diversity is generated is relatively unknown. By studying the role of Satb1 levels in the generation of the diverse features of cortical somatostatin interneuron subtypes, this proposal seeks to uncover basic developmental mechanisms that are used to generate neuronal diversity.